Recruitment, Engagement, Collection, and Analysis Core

ABSTRACT
Adverse Childhood Experiences (ACEs) have been identified as one of the strongest predictors of physical and
mental health outcomes in children and adults and establish a trajectory of physical and mental health across
the lifespan. Understanding the mechanisms/processes of adversity and resilience and how ACEs impact
developmental trajectories will aid researchers and practitioners in targeting specific social and biological
factors for intervention, prevention, treatment, and recovery. Leveraging the science of adversity and resilience
will also impact public health approaches, including programs and policies, as well as awareness, prevention,
and harm-reduction efforts aimed at reducing ACEs and promoting healing and recovery from ACEs . The
Recruitment, Engagement, Collection, and Analysis (RECA) Core is a coordinated team of interdisciplinary
researchers with a shared goal of furthering the science of adversity and resilience by supporting CoBRE
Research Project Leads (RPLs) and Pilot Project Leads (PPLs) as they collect and analyze data that is multi-
method, cutting-edge, and integrated data across Cores and disciplines. Integrated team science approaches
are needed to further scientific understanding of the mechanisms and processes underlying the relationship
between adverse childhood experiences (ACEs) and protective and compensatory experiences (PACEs) and
outcomes and trajectories. Each project lead will be supported by the RECA Core with training and oversight of
recruitment and retention, data collection, and analyses, in collaboration with the Biological Systems and
Administrative Cores. Importantly, we will build a research databank across projects that includes common
assessments of socio-emotional, neurocognitive, physical and mental health functioning, and
environmental/contextual influences on health and related outcomes and will be available for approved
investigators with and outside of the CoBRE. This databank is innovative because it combines data across
multiple domains of biobehavioral functioning affected by adverse and protective childhood experiences in an
area of the country where ACEs are high. These efforts are significant as they will yield transdisciplinary
products to support a sustainable research center and a collaborative cadre of investigators and community
partners focused on preventing ACEs and promoting resilience, resulting in improved health and mental health
outcomes locally and beyond.
1

Public health relevance
NARRATIVE Adverse Childhood Experiences (ACEs) have been identified as one of the strongest predictors of poor physical and mental health in children and adults. Our research core will support recruitment, research engagement, data collection, and data analysis for the broader CoBRE center and project leaders. This will be done through training, individual consultation, and the creation of a common database of assessments across projects that includes biological and behavioral measures that can be used to examine factors that influence trajectories of adversity and resilience across the life course.